Function and Targeting of CCR6/CCL20 in Autoimmune Psoriasiform Skin Disease

DESCRIPTION (provided by applicant): Th17-associated cells and signaling pathways are clearly important in the development of multiple autoimmune processes, including rheumatoid arthritis, multiple sclerosis, and psoriasis. IL23 is a prototypical driver of Th17-mediated inflammation, and we and others have shown that repeated injections of recombinant IL23 in mouse skin result in a psoriasiform dermatitis that mimics many of the features of human psoriasis in as little as 5 days. Among the ~20 known chemokine receptors, CC chemokine receptor-6 (CCR6) is particularly important for Th17-directed immune activity since it is both a marker for T cells that express the Th17 phenotype and a critical participant in several mouse models of autoimmune disease, including autoimmune encephalitis, collagen-induced arthritis, and psoriasis. We have previously shown that CCR6-deficient mice fail to develop psoriasiform dermatitis in skin following IL23 injection. Current models suggest that IL23 produced by dendritic cells (DCs) act to sustain dermal CC chemokine receptor-6 (CCR6)-expressing Th17 cells which then produce IL22 as a major downstream effector that stimulates epidermal hyperplasia through STAT3- mediated mechanisms in human skin. Positive feedback is provided by epidermal and dermal production of CCL20, the CCR6 ligand, potentially recruiting more CCR6+ T cells or CCR6+ antigen-presenting cells into inflamed psoriatic skin. While data from human studies are just beginning to implicate γδT cells in psoriasis and other autoimmune disease, our published data demonstrate that a novel population of CCR6+, Vγ3- T cell receptor (TCR) γδ low (GDL) T cells, distinct from resident dendritic epidermal γδ T cells (DETC), accumulates in murine epidermis following exposure to IL23 and is a major producer of IL22 and IL17 in murine epidermis. We hypothesize that 1) CCR6+ GDL T cells in skin may be critical innate immune cells for the delivery of IL22 and other cytokines that regulate epidermal hyperplasia and inflammation in skin in conditions such as psoriasis and 2) that antagonists of CCR6 or CCL20 would be effective therapeutic agents in several Th17- mediated autoimmune processes, including psoriasis, because of their effects on the trafficking and/or function of CCR6-expressing cells. Based on this hypothesis, we seek to better define the roles of CCR6 and γδ T cells in an IL23- and imiquimod-induced models of psoriasisform dermatitis in mice and to use novel computational methods to identify small molecule lead compounds that antagonize the function of either CCR6 or its ligand, CCL20. Our results will be validated with a SCID-hu psoriasis skin xenotransplant model.

Public health relevance
PUBLIC HEALTH RELEVANCE: Psoriasis is an inflammatory skin disorder with systemic manifestations that affects 2-3% of the world's population. Chemokine receptors, particularly the Th17-associated chemokine receptor, CCR6, have been shown to play a central role in regulating a variety of autoimmune diseases, including psoriasis. The experiments proposed herein seek to better define the role of CCR6 and its ligand, CCL20, in murine models of psoriasiform dermatitis and to identify lead candidates (i.e., small molecules) that will block the CCR6/CCL20 chemotactic signaling pathway through in silico structural methods. __SpecificAimsTextDelimiter__ Specific Aims Based on both clinical and animal data, Th17-associated cells and signaling pathways are clearly important in the development of multiple autoimmune processes, including rheumatoid arthritis and psoriasis8, 9. IL23 is a prototypical driver of Th17-mediated inflammation, and we6 and others10 have shown that repeated injections of recombinant IL23 in mouse skin result in a psoriasiform dermatitis that mimics many of the features of human psoriasis in as little as 5 days. Other Th17 cytokines, IL22 and IL17, are instrumental in the develop- ment of epidermal hyperplasia and dermal inflammation, respectively. Chemokine receptors and their chemo- kine ligands are critical in directed cell movement, survival, and activation of leukocytes and many other cell types. Among the ~20 known chemokine receptors, CC chemokine receptor-6 (CCR6) is particularly important for Th17-directed immune activity since it is both a marker for T cells that express the Th17 phenotype and a critical participant in several mouse models of autoimmune diseases11,12 as well as psoriasis6, 7. We have shown that CCR6 is essential for the development of psoriasiform inflammation in skin6. Moreover, we7 and others2, 4, 13 have recently identified a population of CCR6+, Vγ3- T cell receptor (TCR) γδ-low (GDL) T cells that expresses IL17/22 and accumulates in murine skin following exposure to IL23 or imiquimod. Therefore, hypothesize that CCR6+ GDT cells may play a previously unrecognized, but important, role in the path- ogenesis of psoriasis and will use targeted deletion of GD T cells by genetic or other means to better define their role (as opposed to that of αβ Th17 cells) in the IL23 skin injection model. Although the complete ab- sence of CCR6 abolishes the ability to develop psoriasiform dermatitis in the IL23 injection model, it is unclear at this time which immune cells are truly impacted in terms of skin migration and whether or not CCR6 has roles other than migratory in psoriasiform dermatitis. Thus, we further hypothesize that CCR6 has a key role in directing GDL T cells (and possibly αβ T cells as well) to skin and epidermis and will use mice defi- cient in CCR6 as a principal means of testing this hypothesis. Because abundant data suggest that CCR6 is a highly relevant target for several autoimmune diseases including psoriasis, we propose using state-of-the-art in silico computational and structural methods (in collaboration with two leaders of structure-based drug discovery) to rapidly identify small molecule lead candidates that interfere with CCR6 or CCL20. Antagonizing the chemokine itself is an attractive strategy since the chemokine is locally produced in skin and thus particularly amenable to topical therapy. Promising candidates will be tested in our IL23 skin injection and imiquimod models of psoriasiform dermatitis to determine efficacy. Successful candidates (or derivative compounds) may be therapeutically useful in humans with psoriasis or other Th17-mediated autoimmune disease. We will test our hypotheses with the following Specific Aims: Aim 1- Determine if unconventional GD T cells in the epidermis represent a therapeutic target for psoriasiform dermatitis. We will first use flow cytometry and confocal immunofluorescence microscopy to determine the spatial distribution, phenotype, and other characteristics of Th17-associated immune cells in IL23- and imiquimod-driven murine models of psoriasis and the SCID-hu psoriasis xenotransplant model. The last model will be used to test the sufficiency of isolated human CCR6+ GD T cells to induce psoriasiform dermatitis. Next, we will test the ability of mice of various strains, including ¿¿-, ¿¿-, CD4-, and CD8-deficientT cell-deficient strains to develop psoriasisform dermatitis. Aim 2- Define the role of CCR6 in inflammatory trafficking of conventional as well as unconventional T cells in skin. Using bone-marrow and peripheral immune cells from CCR6 KO mice as well as mAbs that block CCR6 and/or CCL20, we will determine if CCR6/CCL20 is required for inflammatory trafficking of conventional as well as unconventional T cells to the dermis and epidermis of mouse skin using principally the IL23 skin injection and topical imiquimod psoriasiform dermatitis models. Aim 3- Identify lead candidate small molecules that inhibit human CCR6 receptor or CCL20 ligand function. We will use state-of-the-art computational methods based on structural homology of the human CCR6 receptor to the newly solved structure of CXCR4 and other GPCRs to identify potential antagonists from the ZINC database of small molecules. We will also use the same database to identify ligands that bind to predicted sulfotyrosine recognition binding pocket in the CCL20 protein.